The Genetics of Personalized Functional MRI Networks

ABSTRACT
Variability in the spatial layout of human brain functional networks on the anatomic cortex is a novel phenotype
that can be extracted from functional magnetic resonance imaging (fMRI) with transformative potential for
combined imaging-genetics studies of human brain function. Early results show that the individual-specific
topography of Personalized Functional Networks (PFNs) is strongly associated with domains of psychopathology
and cognition, including executive functioning (EF) which is impacted in multiple mental health conditions and
undergoes profound changes during the period of adolescence. PFNs capture individualized aspects of brain
function that have unique associations with clinical and developmental outcomes, compared to standard fMRI
approaches, which can measure activity in these same functional networks but fail to incorporate the variation
in functional network topography that exists among individuals. The over-arching hypothesis of this proposal is
that targeting PFNs will rapidly accelerate the discovery of genetic contributions to the organization of brain
function, leading to mechanistic insights into genetic risks for behavioral health conditions related to brain
function. To this end, we will probe PFNs in genetically informative open fMRI datasets including the Adolescent
Brain and Cognitive Development Study (ABCD, n=11,572, n=850 twin pairs, 5 longitudinal time points during
study period) and the UK Biobank (UKBB, n>40,000), as well as locally acquired fMRI data on the 22q11.2
deletion syndrome (22qDS, n=100; controls n=500). Analyses will yield a cohesive investigation of inherited
polygenic effects and rare, typically de novo copy number variants (CNVs), each of which are hypothesized to
influence individualized functional network topography. First, we will use longitudinal twin models in ABCD to
investigate the twin heritability of PFNs and their genetic correlation with behavioral domains such as EF, for
example, testing the hypothesis that the genetic correlation between EF and association cortex PFNs will
increase during adolescence (Aim 1). Second, we will perform genome- and transcriptome-wide association
studies (GWAS and TWAS) of PFN topography in ABCD and UKBB to prioritize specific, functionally active
genetic loci (Aim 2). Third, we will investigate the influence of rare CNVs on PFNs, using analysis of case-control
Penn/CHOP 22q11.2DS data, in ABCD, CNV Risk Scores that we recently showed to correlate with deviations
from the typical development of brain anatomy in a community cohort (Aim 3). Allanalyses will be conducted
with fully reproducible, transparent imaging processing and genetic pipelines, capitalizing on the PI and
assembled team's joint expertise in advanced fMRI methods, genomics, and informatics. Cumulatively, the
completion of these aims will result in a major advance in our understanding of the genetic contributions to brain
function and its relationship to psychiatric risk, leading to future experimental and clinical trials of targeted
neuromodulation guided by individualized neurogenetics.

Public health relevance
PROJECT NARRATIVE This project applies a recent methodological breakthrough in functional magnetic resonance imaging (fMRI) to investigate genetic contributions to the organization of human brain networks, such as central executive networks, whose functions are critical to a variety of clinical and developmental outcomes. Identifying genetic loci that influence the development of personalized functional brain networks and contribute to psychiatric risk will lead to novel mechanistic insights into network dysfunction in mental illnesses, improved classification of at- risk individuals, and the potential for targeted neuromodulation guided by individualized neurogenetics.